Neural Correlates of Spatial Attention Deployment and Perceptual Decision Making

PROJECT SUMMARY
Each of the 4-5 quick eye movements (saccades) that we generate every second is the result of a target
selection process that combines perceptual and motor planning signals modulated by attention mechanisms,
which prioritize the potential targets. The overarching goal of this project is to reveal how these attention
mechanisms are instantiated in the activity of the frontal eye field (FEF), a key oculomotor area. Specifically, I
propose to record neuronal activity from recognized neuronal types in FEF while monkeys perform two novel
visuomotor tasks. Many studies have investigated how oculomotor neurons contribute to visuomotor choices.
However, most have relied on serialized tasks where a perceptual judgment is made first and a motor report is
made subsequently, and given this structure, the resulting behavioral metrics (accuracy and RT) confound the
contributions of perceptual, motor, and attentional processes to each choice. An effective solution to this
limitation is to impose urgency which, in essence, means that motor plans are always initiated first, before the
task-relevant sensory cue is evaluated. Time pressure yields a novel psychophysical curve, the “tachometric
curve”, which is unique in its ability to resolve the contributions of distinct perceptual signals to the saccadic
choice process as it unfolds in time. Each of my two Specific Aims implements a novel, urgent decision-making
paradigm. In both cases the general strategy is to record FEF activity and, using the time-resolved behavioral
information provided by the tachometric curve, compare the neuronal responses evoked before and after
perceptual information arrives to the circuit. In Aim 1, I plan to use an urgent version of the classic random dot
motion (RDM) discrimination task to determine whether the spatially selective activity in FEF represents the
location where attention is deployed or, alternatively, the amount of sensory evidence that has accumulated in
favor of a choice toward that location. These two functions, attentional deployment and evidence accumulation,
represent entirely distinct theoretical constructs — but are readily confounded in standard, non-urgent tasks.
The proposed dissociation would represent a key conceptual advance. In Aim 2, I plan to use SpotChase, a
gamified, dynamic urgent task, to investigate how visuomotor performance depends on selection history
effects. It is now well established that visuomotor choices are determined not only by ongoing stimulus-driven
and goal-driven signals, but also by past events (stimuli, actions, rewards, etc.) recently experienced.
However, the impact of such selection histories is likely to be much stronger under natural viewing conditions
than in trial-based laboratory tasks. Because SpotChase is highly dynamic but still permits rigorous behavioral
quantification (specifically, construction of tachometric curves), it will afford a much more comprehensive
characterization of the neural basis of selection history effects under more relevant behavioral conditions.
Preliminary data promise significant advances in both Aims.

Public health relevance
PROJECT NARRATIVE The goal of this project is to reveal the neural substrates of the decision of where to look next, a choice that encompasses sensory, cognitive, and motor components. Utilizing two novel urgent choice paradigms, the proposed work aims to delineate the contributions of specific cell types within an oculomotor cortical region to these distinct components with unprecedented temporal precision. The anticipated results will help to elucidate the mechanisms by which the brain makes this decision, and choices in general, which will contribute to our understanding of deficits in these functions associated with neurological disorders.